Resource for Macromolecular Modeling and Visualization

Summary
This administrative supplement application seeks to secure funds to acquire a multi-node,
multi-GPU compute system to be used for code development and optimization of NAMD,
one of the two major programs developed by the Resource for Macromolecular and
Visualization at the University of Illinois Urbana-Champaign. Optimizing the architecture of
NAMD for these modern platforms is a major aim of our parent grant (R24-GM145965),
primarily since this feature is heavily requested by our users. We note that NAMD is
currently used by more than 35,000 users. A large fraction of these users run NAMD using
computational facilities at the National supercomputing centers, many of which have/are
moving towards GPU-dense machines that take advantage of multi-node, multi-GPU
architectures. Therefore, making NAMD compatible with these platforms is of great need
and demand and continues to be a major objective of our Resource. In order to achieve this
goal, we are in need of a multi-node system, with multiple GPUs or multiple superchips
(combined CPU-GPU-memory systems-on-chip) per node, with modern high-speed
connectivity at each level of hardware organization. The requested equipment meets these
architecture criteria and provides a fast communication model to allow us to optimize
NAMD for supercomputing platforms that are already in place at some centers, e.g., TACC.

Public health relevance
Narrative We request funds to acquire a computer system with multiple nodes and GPUs that mimics modern computer platforms at National supercomputing centers and allows us to optimize our molecular simulation program, NAMD, for these modern platforms to make it accessible to the users of the program (currently more than 35,000), many of which rely on supercomputing centers for their research.